In vitro bioreactor production of a genetically modified late liver stage-arresting replication competent Plasmodium falciparum sporozoite vaccine

ABSTRACT
In 2020 malaria caused 241M clinical episodes and 627,000 deaths, a significant increase from 2019. There
were more deaths in Africa from malaria than from COVID-19. There is an urgent unmet medical need for a
malaria vaccine that prevents infection and disease in individuals and can be deployed in mass vaccination
programs for malaria elimination. Based on results of a pilot implementation program in >500,000 infants,
RTS,S/AS01 was recommended in late 2021 by WHO for immunization of 5-month-olds with 4 immunizations
administered over 21 months. RTS,S significantly reduced hospital admissions for malaria by 21% and severe
malaria by 30%. It did not significantly reduce cerebral malaria, severe malaria anemia, or overall mortality, or
prevent Plasmodium falciparum (Pf) infection. Of vaccines under development, only Sanaria’s PfSPZ vaccines
have the efficacy against Pf infection to be considered for prevention of Pf infection in individuals or for
geographically focused Pf malaria elimination campaigns. Sanaria’s 1st generation vaccine, PfSPZ Vaccine, is
comprised of radiation-attenuated Plasmodium falciparum (Pf) sporozoites (SPZ), which arrest early in the liver
stage. Phase 3 clinical trials will begin in mid 2022, and marketing authorizations in Europe (EMA) and the US
(FDA) are planned for 2023/2024. Sanaria’s 2nd generation vaccine is PfSPZ-CVac (Chemoprophylaxis
Vaccine). In PfSPZ-CVac, the parasites replicate in the liver, biologically amplifying the immunogen load by up
to 50,000-fold and then are killed by an anti-malarial drug. PfSPZ-CVac co-administered with chloroquine
(CQ), gave 100% vaccine efficacy (VE) against heterologous controlled human malaria infection (CHMI) 12
weeks after vaccination using 22% the dose of PfSPZ needed to achieve 80% VE against heterologous CHMI
with PfSPZ Vaccine. PfSPZ-CVac (CQ) is more protective than PfSPZ Vaccine at ~1/5 the dose. However,
transient symptoms of malaria can occur after 1st dose of PfSPZ, and if CQ is not administered appropriately,
parasite multiplication in the blood could cause severe malaria. To retain the enhanced potency of PfSPZ-
CVac and eliminate its drawbacks, we genetically altered Pf to be able to fully replicate, but arrest prior to
entering the blood by deleting a single gene. The first of our late arresting replication competent (LARC)
parasites called PfSPZ-LARC1, was completely attenuated in mice with humanized livers and in humans. To
increase the potential safety of PfSPZ-LARC vaccines, we created a parasite with two genes deleted, PfSPZ-
LARC2, which also arrests late in the liver stage. Sanaria has also achieved in vitro production of PfSPZ,
referred to as iPfSPZ, thereby eliminating the need for mosquitoes in manufacturing PfSPZ vaccines and
significantly increasing efficiency and decreasing costs of producing PfSPZ vaccines. In this project we will
optimize in vitro production and purification of iPfSPZ-LARC2, produce aseptic, purified, cryopreserved iPfSPZ-
LARC2 and demonstrate these iPfSPZ-LARC2 are infectious, and can develop into late liver stages but are
attenuated. In the next phase, we will manufacture iPfSPZ-LARC2 for assessment in clinical trials.

Public health relevance
PROJECT NARRATIVE Malaria afflicts over two billion people, killing over 600,000 individuals each year, mostly children in Africa. A powerful tool is needed for eliminating Plasmodium falciparum malaria from defined geographical areas, ideally a highly effective, long-acting yet low-cost vaccine that prevents infection, disease and parasite transmission. This proposal describes the development, manufacture and quality control release of a Plasmodium falciparum sporozoite vaccine produced entirely in vitro, and genetically attenuated to arrest development in the late liver stage, as the basis for a next-generation, scalable whole sporozoite malaria vaccine that is ready for clinical testing.